ShEEP Request for Single Cell System

PROJECT ABSTRACT
This Shared Equipment Evaluation Program (ShEEP) proposal requests a single-cell library preparation system
as a common resource for VA New Jersey Healthcare System (VANJHCS) Investigators. Comprising (1)
Namocell Pala Single Cell Dispenser and (2) 10x Genomics Chromium Connect, this assembled single cell
system will provide five major VA-Merit Award researchers and three minor VANJHCS researchers the ability to
efficiently and reproducibly prepare single cell RNA libraries for sequencing (scRNA-seq), across a diverse group
of VA research priorities in: traumatic brain injury (Drs. Yun-Beom Choi, Bruce Citron, and Vedad Delic),
neurodegeneration & immunology in Parkinson's disease (Drs. James Park and Wei Lu), and melanoma treated
with glutaminergic & checkpoint inhibition (Dr. Suzie Chen), bile acid signaling in infiltrating immune cells during
hepatocellular carcinoma development and progression (Dr. Grace Guo), and T-cell biology such as fate
differentiation during infection (Dr. Hai-Hui (Howard) Xue). The capabilities of this single-cell RNA library
preparation system are not available within VANJHCS and are critical to ongoing and planned research projects.
Human disease begins with the cell. An aberrant transcriptome is one of the first manifestations of incipient
disease but is often masked or convolved by cellular heterogeneity and bulk sequencing. Single cell analysis
reveals insights that are hidden in bulk cell analysis. scRNA-seq has been widely employed to deconvolve under-
appreciated cellular heterogeneity, dissect gene regulatory networks, and reveal novel mechanistic insights
necessary to improve diagnostics and therapeutics. Because of these considerations, single cell analysis is
positioned at the center of a modern high-resolution biomedical investigational tool kit. Reproducible and efficient
single cell library preparation has become necessary. Reproducibility stems from Namocell Pala Single Cell
Dispenser's ability to reliably screen for fully dissociated and viable single cells. High quality single cell input from
Pala Single Cell Dispenser for 10x Genomics Connect is an essential consideration in nervous system, hepatic,
and dermal tissues in which cells are networked by extracellular matrices making single cell preparation
challenging and variable. 10x Genomics Chromium Connect's efficiency stems from the robot's ability to save
an entire working day of investigator liquid-handling time per single cell preparation run. 10x Connect's liquid-
handling consistency ensures the reproducibility of scRNA data. As a bonus, Pala Single Cell Dispenser not only
serves upstream in the library preparation workflow by screening out cellular doublets, debris, and death, the
Pala Single Cell Dispenser can also perform double-duty downstream of 10x Connect by efficiently selecting for
CRISPR-edited single cells, saving a month of investigator-CRISPR screening time. Designing and selecting
CRISPR-edited single cells is often a logical follow-up experiment after scRNA-seq analysis and interpretation.
In summary, the availability of a single cell RNA library preparation system and the ability to efficiently generate
CRISPR-edited single cells will further enable Merit-funded VANJHCS investigators to conduct high-resolution
research on their respective diseases and identify pathways for translational applications in diagnosis, prognosis,
and therapeutic strategies. These endeavors will substantially contribute to the long-term research goals of the
VANJHCS. All VANJHCS Merit projects have significant implications for health, and the single cell RNA library
preparation system we are requesting will facilitate the progress of these productive projects, as well as further
stimulate an esprit de corps in VANJHCS Merit research programs on diseases of high relevance to Veterans.

Public health relevance
PROJECT NARRATIVE This ShEEP proposal requests a single cell analysis system comprising Namocell Pala Single Cell Dispenser and 10x Genomics Chromium Connect to serve as a shared common resource for VA-Merit and VA investigators at Veterans Administration New Jersey Healthcare System (VANJHCS). This single-cell analysis system will allow VANJHCS researchers to obtain high-resolution transcriptomic analyses of the cell populations in various diseases. Multiple VA Merit-funded research projects on melanoma, traumatic brain injury, neuroprotection, Parkinson’s disease, neuroimmunomodulation, fatty liver, hepatocellular carcinoma, and leukemia will benefit from this needed investigational platform for the careful precise study of the cell’s transcriptomic state in health and disease. This proposed system single cell analysis system will augment VANJHCS’s mission to advance Veteran healthcare by incorporating a cutting-edge, but rapidly becoming a standard investigational tool and substantially contribute to the long-term research goals of VANJHCS.